Core C: Infectious Disease Core

CORE C: INFECTIOUS DISEASE
ABSTRACT
Microbiological safety is central to clinical xenotransplantation. The Infectious Disease Core will provide
microbiological surveillance of multi-GE pigs and non-human primate (NHP) xenograft recipients using
advanced metagenomic techniques. We will provide expertise to complement veterinary support. Quantitative
next generation sequencing (NGS) will be provided on cell-free DNA and RNA for panels of known and
common pathogens of swine and NHP and nontargeted sequencing for unknown and unexpected organisms.
Based on experience with clinical and preclinical xenotransplantation, the core will provide data on viruses,
bacteria, fungi, and parasites for which sequence data are available (>20,000). The NGS approach will also
provide potential pathogen discovery to advance screening for clinical xenotransplantation where knowledge of
potential porcine pathogens is limited. We will apply screening using hybrid capture for viral target enrichment
for Whole Transcriptome Sequencing using a Comprehensive Viral Capture Panel (targeted and non-
targeted) to validate this technique and increase assay sensitivity via detection of viruses not found by
standard NGS. Samples will be obtained from xenograft recipients in each Project under either standard or
costimulatory blockade-based immunosuppression. These data will be provided to Projects as a basis for
refining management of antimicrobial prophylaxis, adjusting intensity of immunosuppression, and provide
sequences for spatial transcriptomics probes in the pathology core to further document the presence of
infection in specific xenograft tissues and cells(B).